Rochester Resource-Based Center for Bone, Muscle and Orthopaedic Research (ROCSTARR) (Overall Application)

This is a proposal to sustain the University of Rochester Resource-based Center for Bone, Muscle and
Orthopaedic Research (ROCSTARR) Program. ROCSTARR is comprised of an Administrative Core that will
run the Enrichment Program, and will coordinate and integrate the Histology, Biochemistry and Molecular
Imaging (HBMI) and the Biomechanics, Biomaterials and Multimodal Tissue Imaging (B2MTI) Cores, in order to
ensure progress of the overall ROCSTARR in an efficient manner. The Core Users Committees, the URMC
Shared Resource Laboratories & Facilities, and the meeting structure of the Administrative Core are key
elements that organize communication and collaboration among the ROCSTARR investigators, as well as with
other faculty in the Center for Musculoskeletal Research (CMSR) and collaborating Departments and Centers
within the University. The Specific Aims of the ROCSTARR are: 1) To maintain state-of-the-art resource-
based Cores for basic science, translational and clinical musculoskeletal research; and utilize these resources
in a cost-effective manner to accelerate the pace of discovery and clinical translation. 2) To continue to foster
our highly collaborative environment that serves as a model for translation of basic research to clinical trials,
and expands our outreach activities that promote the use of the resources offered by the Core to new external
collaborations with the aim of growing our musculoskeletal research base at URMC, nationally and
internationally. 3) To: i) maintain our exceptional 42-fold return on investment from Pilot Grants awarded to
New/Early Stage Investigators (N/ESI), ii) commence utilization of a new Discovery Fund created with small
endowments for research in the prior funding period, and grow it via targeted philanthropy, and iii) sustain our
renowned academic Enrichment Programs including the William F. Neuman Visiting Professor series and the
Annual Musculoskeletal Research Symposium. 4) To maintain our Sub-Cores that administer: i) human
subject research services in concert with the Clinical-Translational Research Institute, ii) biostatistics, computer
programing and outcome research resources to grow collaborative networks in Big Data science, surgical
outcomes and population health research, and iii) provide new resources for muscle and exercise biology
research in animal models and human subjects. And, 5) to expand our highly successful Mentoring Program,
which facilitates the advancement of our N/ESIs to NIH R01 funded PIs with national leadership status, and
implements the highest standards of scientific rigor in response to NIH’s plan to enhance reproducibility. Thus,
building on our remarkable successes during the prior funding period, this P30 Core Center proposes to
continue its mission “To advance our faculty members to independence, establishing them as national leaders
and the most desirable faculty in their field by the top academic programs in the country, upon which the
ultimate success of this Core Program will be judged.”

Public health relevance
Overall Program Narrative Based on the remarkable success of this Program during the prior funding period, this is a proposal to sustain the University of Rochester Resource-based Center for Bone, Muscle and Orthopaedic Research (ROCSTARR), which will continue to provide critical research infrastructure, shared facilities, services and resources to all investigators conducting research on musculoskeletal biology and medicine at the University of Rochester and their collaborators, with the broad overall goal of accelerating, enriching and enhancing the effectiveness of ongoing basic, translational and clinical research and training the next generation of musculoskeletal investigators.